DIRECTED COUNSELING--EFFECTS ON CONTRACEPTIVE BEHAVIOR

Research suggests that a substantial proportion of women who describe themselves as contraceptive users are using contraception ineffectively, thereby putting themselves at risk of unintended pregnancy. Numerous studies attest to the importance of women's beliefs about contraception and pregnancy in explaining ineffective contraceptive use. The relationship between beliefs and contraceptive use can be conceptualized in the Health Belief model, which posits that contraceptive behavior is a function of perceived susceptibility to pregnancy, perceived severity of pregnancy, and perceived benefits and barriers to contraceptive use. Due to time and personnel constraints, family planning providers have little opportunity to elicit and discuss these beliefs with their clients. This project designs and evaluates a method by which counselors can efficiently address those beliefs that may put clients at risk of unintended pregnancy. The method uses a questionnaire, filled out by clients waiting for services, as a risk assessment tool; counselors will be given access to this risk assessment tool and will be trained to use it to guide their counseling. Subsequent contraceptive behavior will be compared between three groups: 1) women who receive standard counseling according to the current protocol, 2) women whose counselors were trained to address "risky" beliefs but were not given access to the tool, and 3) women whose counselors had access to the tool. 525 women visiting Planned Parenthood of Metropolitan Washington who are seeking oral contraception but are not currently using it will be asked to participate in the study. The first 175~participants will receive standard counseling. The next 175 will receive standard counseling by specially trained counselors, and the final 175 will receive individualized counseling from the same trained counselors who will now have access to their risk assessment tools. All participants will complete the risk assessment tool, a client satisfaction questionnaire, and be called after three months to assess contraceptive behavior and changes in beliefs. Behavioral outcomes to be assessed include 1) continuation of oral contraceptive use, 2) consistency of oral contraceptive use, and 3) consistency of overall contraceptive use, including women who discontinue oral contraceptives or use them inconsistently. Staff perceptions of the interventions will be assessed, as will the efficiency and feasibility of the interventions. If the tool is successful, it will help family planning providers improve both the efficiency and the quality of services at a negligible cost.